Building an evidentiary case for circulating GHBP as a biomarker for drug-associated stunting of growth

There is increasing interest in the use of biomarkers in clinical drug development, with much of the 21st Century Cures Act focused on encouraging this approach. Ideally, biomarkers could provide and acute and objective read out of drug mechanism of action (pharmacodynamic biomarkers), or prediction of later clinical benefit or harm (surrogate outcome measure). However, very few biomarkers have been validated for routine use in drug development. This is due to the need to fulfill stringent yet reasonable requirements at multiple levels, including defining specific context of use, showing that a specific biomarker is fit for purpose (in a context of use), and demonstrating assay validity for assessments of the biomarker (precision, sensitivity, reliability). Glucocorticoids (prednisolone and deflazacort) are among the most extensively prescribed drugs, with about 90 million prescriptions per year in the US. They show potent anti-inflammatory efficacy, but also extensive safety concerns with long-term use in chronic inflammatory states, particularly in pediatrics. Stunting of growth is seen with both prednisone and deflazacort treatment, and is one of the chief complaints of patients and families regarding side effects of these drugs. While stunting of growth is a clear safety concern of importance to patients and families, it is challenging to accurately assess in clinical trials due to the large variance in growth rates of different children. Here, we propose research focused on building an evidentiary package on the use of circulating GHBP (growth hormone binding protein) as a surrogate biomarker anticipating later stunting of growth as a safety concern of drug treatment. ReveraGen Biopharma is a privately owned small business based in Rockville, MD. In published pre-clinical studies in mouse models of human chronic inflammatory states, we demonstrated that glucocorticoid-induced growth stunting could be assessed after a 6- week prednisolone regimen and that this in vivo assay is sufficient to compare different treatments in terms of their ability to cause stunted growth. Furthermore, in our recently published pharmacodynamic biomarker studies of anti-inflammatories in children we found the extracellular domain of human growth hormone receptor (growth hormone binding protein; GHBP) to be at high levels in the sera of glucocorticoid-treated children. In unpublished data in the mdx model of DMD, we found prednisolone to result in increased GHBP in serum. As GHBP is considered inhibitory to hGH/GHR signaling, we hypothesize that steroid-induced GHBP may be a biomarker predictive of later growth stunting. !

Public health relevance
Stunting of growth is seen with glucocorticoid treatment, and is one of the chief complaints of patients and families regarding side effects of these drugs. However, it is challenging to accurately assess growth stunting in clinical trials due to the large variance in growth rates in different children. The goal of the proposed STTR research is to build an evidentiary case for GHBP as a ‘fit for purpose’ biomarker for monitoring of drug- induced stunting of growth.